Analytical Imaging Facility

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
ANALYTICAL IMAGING FACILITY - PROJECT SUMMARY/ABSTRACT
The Analytical Imaging Facility (AIF) is a comprehensive shared resource that offers a broad spectrum
of imaging technologies to MECC investigators for both pre-clinical experimental and clinical samples.
The AIF also provides a comprehensive, expert, and cost-effective histology and histochemistry
service, including tissue fixation and processing, paraffin and frozen embedding and sectioning,
standard and specialized histochemical stains, enzyme histochemistry, and
immunohistochemistry/immunofluorescence. In addition, AIF supports translational studies and has a
designated microtome for cutting fresh-frozen human samples for research, as well a high-throughput
automated slide stainer for uniform processing and staining of patient samples from clinical cohorts in
the Translational Pathology Core (TPC), which is a service of the AIF. Analysis and digital quantitation
of histology slides is possible using a high-speed, high-capacity automatic slide scanner. Imaging
services include brightfield, epi-fluorescence, confocal, multiphoton, super-resolution (STORM & SIM),
transmission and scanning electron microscopy (TEM & SEM), cryoTEM, cryoSEM, electron
tomography, correlative light and electron microscopy (CLEM), and quantitative image analysis. Finally,
AIF provides in vivo MRI, CT, PET, and SPECT analysis of tissue metabolism, oxidative changes, and
tumor dissemination, scalable from mouse models to humans. The overall aim of AIF is to provide the
most up-to-date sample preparation and imaging resources for a wide range of basic and translational
cancer-relevant studies, and to deliver these services in the most convenient and cost-effective manner
possible. In addition, the AIF focuses on providing training of users at all levels of expertise in imaging
and image analysis techniques.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward ANALYTICAL IMAGING FACILITY - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page